Administrative Core

PROJECT SUMMARY: Administrative Core
The Administrative Core for the Program Project Grant (PPG) will provide scientific leadership, administrative
support, and fiscal management for the PPG, as well as facilitate efficient communication among Program
Project investigators. It will serve to coordinate administrative interactions among the leaders and all scientists
within the PPG, in order to facilitate the successful accomplishment of the scientific goals. This Core will
oversee the facilitation and organization of regular meetings of the Steering Committee (Project and Core
Leaders). Agendas for these meetings will include review of progress on the overall goals of the PPG. The
reviews will also include assessments of the logistics of all interactions between Projects and Core in order to
identify any potential bottlenecks in transfer of specimens, data, protocols, funds, or other items. The Project
and Core Leaders will also review expenditures and allocations of resources for all Projects and Cores at least
twice per year. Reports from the Internal and External Advisory Committees will be collated and reviewed by
the Project and Core Leaders following each annual PPG review, which will occur during the annual retreat.
The Administrative Core will oversee collection and collation of annual reports from all Project and Core
Leaders and compiling them into the annual progress reports to NIH.